Core 2: Biocomputational and Biostatistics Core

PROJECT SUMMARY/ABSTRACT—Core 2 Biocomputation and Biostatistics
The purpose of Core 2 Biocomputation and Biostatistics is to provide computational and statistical support
to the four Projects in this P01, and to collaborate with Cores to provide to address such computational and
biostatistical needs as required to accommodate the needs of the projects. This assures that the design,
conduct, and analyses of all experiments—clinical, correlative, animal, or basic science--use robust statistical
techniques that are appropriately implemented, and that the specialized resources to analyze and interpret
single cell RNA sequencing results are available to the projects on a priority basis, for cells from clinical trial
patients, from cell lines developed from those patients, and from murine experiments.. This central resource
thereby helps to elucidate the changes in T cell activation and attenuation that result from immunologic
interventions in GBM.

Public health relevance
PROJECT NARRATIVE— Core 2 Biocomputation and Biostatistics The goal of Core 2 Biocomputation and Biostatistics is to assure that all experiments conducted through this P01 focused on T cell activation and attenuation in glioblastoma multiforme have access to state-of-the-art computational support for the single cell RNA sequencing analyses which are critical to each of the projects, and to state-of-the-art statistical support for design and analysis of all clinical, correlative, murine, and basic laboratory projects. This assures that the work of this GBM P01 will be robust and reproducible, and thereby contribute to understanding the changes in T cell activation and attenuation that result from immunologic interventions in GBM.